Central role of Caspase-8 in control of host tolerance and resistance mechanisms in pulmonary macrophage populations during severe respiratory infections

Parent grant: R01 HL165259
Title: Central role of Caspase-8 in control of host tolerance and resistance mechanisms in pulmonary
macrophage populations during severe respiratory infections
PI: Amanda Jamieson
A. Abstract of the parent grant:
Pneumonia is an important global health problem1. Influenza A virus (IAV) leads to an estimated 500,000
deaths annually, and these numbers can be even higher during IAV pandemic years 2. A complication following
infection with IAV is bacterial pneumonia, and this can lead to a more severe disease 3–21. To survive a given
infection hosts must be able to not only clear the pathogen, but also tolerate to the effects of the pathogen or the
host response. The latter processes are referred to as disease tolerance. Normally, a balance between these
two processes is reached, and the infection resolves22,23. My research lab has been at the forefront of exploring
the concept of host disease tolerance in deadly complex respiratory infections22–26. We have shown that during
pulmonary IAV/bacterial coinfection this balance between resistance and tolerance is disrupted causing
increased lethality23,26.
Regulated cell death (RCD) plays important roles in both resistance and tolerance to infection. Cell death
can be broadly categorized as membrane permeable (e.g. necroptosis and pyroptosis) or membrane
impermeable (e.g. apoptosis). During infection several different types of cell death can be induced each inducing
a unique response. Macrophages are responsible for both resistance mechanisms such as coordination of the
immune response, and they contribute to tolerance in the form of the tissue repair responses after damage. This
proposal aims to bridge gaps in our current understanding of complex respiratory infections by investigating the
role of Caspase-8, a key regulator of RCD, in relevant in vitro and in vivo models of IAV/bacterial coinfection.
We will focus on understanding how Caspase-8 pathways in lung macrophages during IAV/bacterial coinfection
contributes to resistance and tolerance. Our preliminary data has demonstrated that Caspase-8 deficiency in
macrophages leads to increased host resistance at the expense of host tolerance in the early stages of
coinfection. This is most likely due to increased necroptosis and anti-microbial responses. We hypothesize that
during severe lung infections such as those that occur with bacterial infection following IAV infection
macrophage cell death controlled by Caspase-8 plays an important role in regulating the balance
between resistance and tolerance.
In this study we will determine the role that Caspase-8 in macrophages plays throughout the course of
infection. We will use relevant in vitro models using human primary macrophages, as well as in vivo models.
These studies will lay the foundation for future studies on understanding the impact of RCD in
macrophages during complex pulmonary infections, which may ultimately lead to improved treatment
options for patients with complex and severe lung infections.
B. Specific Aims of the parent grant
Aim 1: Determine the role for Caspase-8 in resistance and tolerance functions using in vitro models of
coinfected alveolar macrophages.
Aim 1a: Determine the impact of Caspase-8 on the role of mouse macrophages in coinfection by using
pharmacologic inhibitors and genetic models.
Aim 1b: Determine the impact of Caspase-8 on the role of human macrophages in coinfection by using
pharmacologic inhibitors and genetic manipulation.
Aim 1c: Determine the role of direct infection and bystander effect on Caspase-8 dependent cell death modalities
in macrophages
Aim 2: Using in vivo systems, determine the role of Caspase-8 in clearing pathogens while maintaining
host tolerance to lung infection.
Aim 2a: In the context of a whole lung we will test the hypothesis that Caspase-8 plays an essential role in
controlling cell death modalities that influence resistance and tolerance responses by macrophages to pulmonary
IAV/bacterial coinfection.
Aim 2b Determine the impact of Caspase-8 on host resistance and tolerance mechanisms in macrophage
subsets during lung infection and coinfection
Aim 2c Determine impact of Caspase-8 in macrophages over the course of pulmonary infection and coinfection
C. Research Plan for Supplement
This is in response to:
Notice of Special Interest (NOSI): Availability of Administrative Supplements for the INCLUDE (INvestigation of
Co-occurring conditions across the Lifespan to Understand Down syndromE) Project
Notice Number: NOT-OD-22-137
Title:
Excessive Type I Interferon Signaling in Down Syndrome Promotes Macrophage Dysfunction and Cell
Death, Increasing Susceptibility to Bacterial Pneumonia following influenza A virus infection
Abstract
Individuals with Down Syndrome (DS, Trisomy 21) face a significantly elevated risk of severe respiratory
infections, particularly bacterial pneumonia. We propose that this susceptibility is driven in part by chronic
overactivation of Type I interferons (IFN-I), a consequence of gene dosage effects on chromosome 21, which
harbors four of the six IFNR genes. While IFN-Is are essential for antiviral immunity, their dysregulation is
associated with immune exhaustion and impaired antibacterial responses. This has been shown in several
studies where respiratory bacterial infection follows pulmonary viral infection. Macrophages, critical first
responders in lung infection, are particularly sensitive to cytokine environment and are central to host defense
against bacterial pneumonia. We hypothesize that heightened IFN-I signaling in DS drives macrophage
dysfunction and death, impairing bacterial clearance and promoting pneumonia severity. This proposal aims to
delineate the mechanisms by which IFN-I overactivation impairs macrophage viability and function in the context
of DS, identifying potential therapeutic targets to reduce infection-related morbidity. This supports the National
Heart, Lung, and Blood Institute (NHLBI) goals of “providing global leadership for a research, training, and
education program to promote the prevention and treatment of heart, lung, and blood disorders and enhance the
health of all individuals so that they can live longer and more fulfilling lives”. The INCLUDE (INvestigation of Co-
occurring conditions across the Lifespan to Understand Down syndromE) contribution from NHLBI contributes
by focusing on pulmonary function specifically other respiratory complications associated with DS. This
supplement will fulfill component 1: Targeted high risk - high reward basic science studies in areas highly relevant
to Down syndrome Co-occuring conditions that also impact the general population.

Public health relevance
PROJECT NARRATIVE According to the WHO seasonal influenza epidemics causes 3-5 million illnesses and about half a million deaths each year, and a major cause of morbidity and mortality from influenza infection is caused by secondary infection with bacterial pathogens. This project focuses on the role of an innate immune cell subset, the macrophage, and in particular cell death responses in the overall ability to clear complex respiratory infections with minimal morbidity and mortality. This will allow us to better understand a fundamental concept of complex respiratory infections.